Computational Medicine in the Heart, Integrated Training Program

Project Summary
Cardiovascular (CV) diseases are rising causes of morbidity and mortality worldwide. There is
excitement that computational medicine, an emerging field combining engineering disciplines with the life
sciences, will enable scientific and clinical breakthroughs and accelerate bench-to-bedside translation.
However, few training programs exist in this field, and so trainees often learn ad hoc.
We seek funding for a new multidisciplinary T32 program in Computational medicine in the Heart:
Integrated training Program (CHIP) at Stanford. CHIP will provide cutting-edge training for 3 post-PhD, -MD or
-MD/PhD fellows annually, each undergoing 2 years of training at the intersection of engineering, CV
physiology and medicine. Trainees will pursue a cutting-edge research project mentored by faculty with
complementary expertise in engineering and the life sciences, and select didactic courses to build expertise,
grow professionally, and develop community. The forward-looking vision of CHIP addresses key priorities of
several National Agencies and fills current gaps in interdisciplinary training.
Stanford CHIP leverages faculty and resources at top-ranked Schools of Engineering, Medicine and
Humanities and Sciences. The T32 is co-directed by a physician-engineer and an engineer-physiologist,
bringing 38 faculty from 13 Departments and Divisions with strong emphasis on women and under -
represented minorities. Key support is provided by the inter-disciplinary Cardiovascular Institute (CVI) and the
Institute for Computational and Mathematical Engineering (ICME) at Stanford. Faculty will provide trainees with
research opportunities in CV science spanning cell-to-organ and bench-to-bedside, as well as computational
science, clinical care, and therapeutic innovation. The faculty are highly collaborative and have exceptional
track records of launching trainees into independent scientific careers.
Applicant selection and all aspects of the program stress inclusion of trainees from under-represented
groups. Trainees will not be required to have backgrounds in both engineering and life sciences. The T32 will
provide tailored teaching of CV science to engineers, engineering to life-science fellows, and advanced cross-
disciplinary topics to each. Core didactics also include ethics, the responsible conduct of science, methods to
ensure reproducibility. Diversity, equity and inclusion are central for trainees and faculty. Evaluation will be
both constructive and bidirectional between trainees and faculty.
In summary, the CHIP T32 at Stanford provides post-MD, post-PhD and post-MD/PhD graduates with
world-class training at the intersection of bioengineering, CV science and medicine. The T32 is well positioned
for success due to the co-location of these top-tier resources on a single campus in Silicon Valley, a hub of
innovation in data science, artificial intelligence and therapy. Our aspirational goal is that CHIP graduates
will become global scientific leaders at the cusp of engineering, physiology and medicine.

Public health relevance
Narrative There is excitement that combining engineering and computational disciplines with the life sciences may enable major breakthroughs in the cardiovascular (CV) sciences, yet few training programs exist at this intersection. This new T32 at Stanford provides cutting-edge training for post-PhD, -MD or -MD/PhD fellows combining engineering, CV physiology and medicine that is focused on mentored research, didactics, professional growth, training in diversity, ethics and other key topics. The T32 is well positioned for success due to an excellent pool of applicants, dedicated interdisciplinary faculty, and co-location of top-tier schools of Engineering, Medicine and Humanities and Sciences on a single campus in Silicon Valley.